Leveraging Existing Data and Analytic Methods for Health Disparities Research Related to Aging and Alzheimer's Disease and Related Dementias (ADRD)

Abstract
The next two installments of a series of hybrid virtual/in-person workshops to be held in 2023-2024 are proposed.
The aim of these two sessions is to provide new knowledge on how existing and recently developed analytic
methods can be used for detailed, reliable, and reproducible analysis to make progress in understanding the
causes and mechanisms of health-related disparities in Alzheimer’s disease (AD), related dementias (ADRD),
and other prominent age-related diseases. The long-term goal of the series is to provide a resource focused on
diffusing methodological know-how, demonstrating the capabilities of newly developed methodologies,
expanding on the rigor and range of application of well-established methods, promoting correct use of big health
data both from a methodological and ethical prospective as well as providing a forum for experts and newcomers
interested in health disparities and age-related diseases to discuss their ideas and showcase their research. In
the planning of the 2023-2024 workshops, we will continue the important work that has already been done by
our team and build upon the accomplishments of previous Symposia and Workshops in this series including
those funded by the parent grant of this proposal (R13AG069381). As has become customary over the course
of the series the exact schedules of the 2023/2024 workshops will be finalized after receiving input from
2022/2023 participants. We have had great success in using this model as evidenced by active participation of
representatives of Alzheimer's Disease research centers, minority institutions, and other methodological focus
groups as well as the increasing attendance of our workshops and symposia. The overall focus of the workshops
will be: “Evaluating heterogeneity and Structure in AD/ADRD risks and outcomes” for 2023 and “Determinants
of AD/ADRD risks: application of innovative methodologies to Big Health Data” for 2024. Each workshop will
contain three substantive and one supporting methodologic session. The list of substantive sessions will include:
i) patterns of mixed dementia and their components, ii) trends and disparities in AD/ADRD survival, iii) the
COVID-19 pandemic and AD/ADRD risk and outcomes, iv) role of younger ages in the risk of AD and associated
disparities, v) multimorbidity/comorbidity and AD risk, and vi) non-clinic-related determinants of the risk of
AD/ADRD and their role in time trends and health disparities. The methodologic session will discuss supportive
approaches that will deal with multiple modern administrative, population, and clinical datasets. We plan to
maintain the accessibility level of the methodologic presentations by combining methodological innovations with
practical hands-on demonstrations while addressing topics of the highest interest to the audience based on
feedback gathered using pool and post-event surveys administered over the course of past Workshops.
Furthermore, by bringing researchers together in a unified format rather than separating them across field-
specific sections we endeavor to overcome the fragmented nature of the fields involved in such research by
centering it around the application of methods and data, making it especially useful for early career investigators.

Public health relevance
Narrative Our objective is to host two hybrid virtual/in-person workshops in 2023-2024, in which research findings, evidence-based information and analytic tools for analyses of health-related disparities in Alzheimer’s disease, related dementias and other prominent age-related diseases are comprehensively discussed. Specific Aims to be addressed in this project will be focused on increased collaboration and partnership in an interdisciplinary research community focused on analytic methods for large-scale population and clinic-related data, constructing a bridge between independent research subgroups, and the identification of ways to achieve synergistic effects in multidisciplinary research by combining innovative approaches developed across different research groups. Ultimately, our long-term goal is to diffuse the active use of advanced analytic methods for analyses of existing big health population datasets in health disparity research.